Impact of preconception and onward exposure to air pollution on growth trajectories of infants and children (R01)

PROJECT SUMMARY/ABSTRACT
Childhood obesity is a risk factor for many chronic diseases in childhood and adulthood. Excessive calorie
consumption, inadequate physical activity, and genetics are important factors in the burgeoning obesity epidemic;
but emerging evidence suggests a role for early-life exposure to air pollution, beginning at the preconception
period of gametes maturation and continuing into the entire childhood. Despite that 92% of world’s population
today lives in places where ambient air quality exceeds health-based limits per a 2016 WHO report, no published
studies have assessed the potential critical time windows, including the preconception period, during which air
pollution exposures may adversely affect birth weight and growth trajectory, two significant predictors for
childhood obesity.
Here we present an overarching hypothesis that air pollution exposures during critical early
life developmental periods of preconception, in utero, and first 2 years of life, are associated with obesity-related
developmental perturbations, which is manifested by low birth weight and higher growth trajectories during early
childhood. We propose to examine this hypothesis in 20,000 newborns whose fathers and mothers have both
been enrolled in the Shanghai PreConception Cohort (SPCC) throughout 29 hospitals from year 2016-2018.
Each of these newborns has detailed paternal and maternal preconception baseline health, dietary supplement,
smoking, alcohol consumption, and demographic data, detailed maternal gestational information, and birth
outcome data. During their first 2 years of life, these newborns have up to 6 scheduled physical and health
exams, providing data for us to calculate weight and height, potentially non-linear, growth trajectories and assess
relevant postnatal variables such as breast-feeding, infection, and illness. Across the 20,000 residence
addresses of study subjects, there exist unusually large temporal and spatial variabilities in pollutant
concentrations especially for traffic related air pollutants. We will use cutting-edge tempo-spatial exposure
models, validated with air monitoring data from 10 governmental stations and our supplementary air pollution
measurements, to compute pollutant concentrations at residence addresses for a set of specified time windows
including sensitive preconception periods for mothers and fathers (respectively), gestational months and
trimesters, and throughout the first 2 years of infancy. By leveraging the rich dataset of this large longitudinal
cohort of 20,000 children,
we will use distributed lag models to identify critical exposure windows and to examine
potential effect differences by factors such as child sex, social economic status and parental smoking status
from preconception to gestation periods. If our hypothesis is proven true, this study will provide the first scientific
evidence supporting paternal and maternal air pollution exposure during critical time windows, including
preconception and in utero periods, as a risk factor for low birth weight and excessive body growth in childhood.

Public health relevance
PROJECT NARRATIVE This project will fill critical knowledge gaps in our understanding of the effect of early life exposure to air pollution, starting from sensitive preconception periods of gametes maturation and continue through gestational process and infancy, on birth weight and growth trajectory in early childhood. Both lower body weight and excessive body growth are significant predictors of childhood obesity.